Discipline: Two - Track: Three

Project Summary DB/T3 Animal Food Product Testing The purpose of this analytical track is to improve animal food testing surveillance programs through the chemical analysis of animal food products. The test results generated by these laboratories can be used to remove adulterated animal food from commerce and aide regulatory inspection programs in conducting investigations. WI BLS will work with the Division of Agriculture Management (DARM) on a 5-year project to collect Feed commodities such as Fish meal, rendered products Cattle feed and various other feed ingredients and test them for mycotoxins and heavy metals. In year two of the track, we will add pesticide testing as well. Additionally in years, 2 or 3 sample volumes could increase to 250 samples.